Mutational Analysis of Putative Genetic Elements Required for Vmp Regulated Expression and Antigenic Variation by the Relapsing Fever Agent, Borrelia hermsii

Summary
Borrelia hermsii is a causative agent of tick-borne relapsing fever, which is a bacterial illness
characterized by severe recurrent febrile episodes. The undulating fever that is characteristic of the disease is a
direct result of Vmp antigenic variation and sequential immune evasion by the pathogen. Recent work in our lab
has provided evidence that a region upstream from the vmp locus may be involved in the regulation of Vmp
expression, and that a mutant clone deficient in vmp expression was unable to undergo vmp recombination.
Additionally, a mutant clone lacking an inverted DNA repeat residing in a downstream homology region did not
exhibit Vmp antigenic variation. Despite these advancements, the exact identity and role of cis-acting genetic
elements in vmp regulated expression and recombination remain unknown. The objective of our application will
be to identify cis-acting DNA regions of the vmp locus that are important for vmp regulated expression and
recombination. Based on published and preliminary findings, our central hypothesis is that the tandem inverted
repeat sequences are involved in the regulated expression of vmp, and that vmp transcription is required for the
gene conversion process. Additionally, we hypothesize that it is the secondary hairpin structure of the DHS-
resident inverted repeat sequence that is essential for vmp recombination. The rationale for addressing these
knowledge gaps is that the resulting outcomes will lay the groundwork for additional investigations aimed at
disrupting the antigenic variation system that underpins the pathogenesis of disease. Thus, the proposed
research is relevant to that part of NIH’s mission that pertains to developing fundamental knowledge that will
potentially help to reduce the burdens of human illness and disability.
Our central hypothesis will be tested by pursuing three specific aims: 1) Determine the role of the tandem
inverted repeat sequences for regulated expression of vmp, 2) Determine the importance of vmp expression for
gene conversion, and 3) Establish the requirement of the DHS-resident inverted repeat structure for vmp
recombination. Under the first aim, individual inverted DNA repeats will be deleted using our telomere-mediated
deletion/complementation technique. Transcription and translation of vmp from mutant clones or an isogenic wild
type control will be determined via qRT-PCR and Western blot analysis, respectively. Additionally, mRNA
transcript levels will be quantified from blood samples obtained from infected mice at varying time intervals and
compared to those from the wild type control. Under the second aim, mutations will be generated within the vmp
promoter region and used to infect mice to look for a loss of antigenic switching compared to a wild type control.
In the third aim, the inverted repeat within the DHS will be interrupted or DNA sequence altered while retaining
the overall sequence length. Antigenic variation compared to the wild type control will be monitored after infecting
immunocompetent mice. Overall, our experimental approach will allow for direct mutational analysis of putative
cis-acting elements to gain further understanding of this immune evasion system of B. hermsii.

Public health relevance
Project Narrative The proposed studies are of an important area of relapsing fever research that has potential applicability to understanding immune evasion and persistence by Borrelia hermsii and other relapsing fever-causing Borrelia species. The proposed research has relevance to public health because the resulting discoveries have the potential to fundamentally advance the field of immune evasion by relapsing fever Borrelia species, and may have broad implications for antigenic variation systems in other animal and human pathogens. Thus, the findings are ultimately expected to be applicable to the health of human beings.